COMPASSIONATE USE OF THALIDOMIDE IN ADULTS WITH HIV ASSOCIATED WASTING

To provide thalidomide to eligible patients with HIV associated wasting and monitor it's safety and efficacy. Follow up for patients studied under protocol #400.